Subclonal determinants of radiation response in soft tissue sarcomas

PROJECT SUMMARY
Although more than half of patients with cancer receive radiotherapy, the molecular mechanisms that
determine the success of radiotherapy remain unclear. Subclonal populations of malignant cells with mutations
that occur later during tumor development play an important role in response to treatments like radiotherapy.
The overall goal of this study is to understand the non-genetic mechanisms that enable subclonal tumor
populations to survive radiotherapy. By analyzing tumor and blood samples collected from patients undergoing
preoperative radiotherapy for soft tissue sarcomas, this study will determine the cell intrinsic and extrinsic
factors that contribute to subclonal radioresistance. Using genomic and computational biology approaches, this
research aims to 1) identify and validate epigenetic changes such as changes in DNA methylation or chromatin
accessibility that cause subclonal radioresistance, 2) define and validate critical interactions between
radioresistant subclones and non-malignant cell populations in the tumor microenvironment, and 3) develop
approaches to non-invasively localize and monitor radioresistant subclones within human tumors. Future
studies targeting radioresistant subclones with combination therapies and new radiation delivery approaches
could improve the efficacy of radiotherapy for patients with soft tissue sarcomas and other cancers.

Public health relevance
PROJECT NARRATIVE Subclonal tumor cells that acquire mutations and epigenetic changes later during tumor development play a critical role in the response of tumors to treatment. This study will establish the key mechanisms underlying radioresistance within subclonal tumor cells in human tumors. These results will enable the development of new combination therapies and radiation delivery approaches targeting these populations to improve the efficacy of radiotherapy.